STRUCTURE OF A C-TERMINAL PEPTIDE OF TRPV1 BOUND TO CALMODULIN

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We are interested in the interaction of calmodulin with the Transient receptor potential vanilloid 1 (TRPV1) ion channel. Calcium and calmodulin are important inhibitors of TRPV1, causing desensitization and regulating the sensitivity of TRPV1 to temperature.